THE METABOLIC EFFECTS OF MATERNAL EXPOSURE TO HIGH-FRUCTOSE DIET ON THE FETUS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The prevalence of obesity and metabolic disorders in children has increased dramatically in the U.S. and worldwide over the past several decades, and has largely been attributed to an increase in the consumption of calorically dense foods and decreased physical activity in the pediatric population. Prenatal metabolic events and exposures also likely contribute to the increased risk of childhood metabolic disorders. Given the current state of nutrient excess in our society the potential adverse lifelong consequences on the fetus from maternal obesity and/or metabolic syndrome is concerning. This study focuses on the metabolic effects of fructose consumption during pregnancy on the developing fetus.